Psychosocial and Neighborhood Mechanisms and Consequences of Black-White Sleep Disparties on Cognition

FUNDED PARENT UF1 SUMMARY
African American/Black adults are at an elevated risk for mild cognitive impairment (MCI) and Alzheimer's
disease and related dementias (ADRD)1–3.Thus, the identification of modifiable factors underlying this
heightened risk is urgently needed. One such modifiable factor essential to cognitive health is sleep.
Specifically, sleep is associated with impaired cognitive functioning and risk for mild cognitive impairment,
particularly within Black adults4–6. Additionally, life stressors and protective/resilient factors are associated with
cognitive and sleep health7–12, but limited research has revealed how all these factors interconnect to explain
observable differences in cognitive functioning within Black adults. Understanding these associations is even
more pressing in midlife – a period of life (a) where the sleep-cognition relationship has not been extensively
investigated, (b) for which Black people are at a high risk of cognitive dysfunction, and (c) represents an ideal
period to target for intervention13. The overall objective of this study, branded Healthy Aging in Neighborhoods
of Diversity Across the Life Span (HANDLS) Sleep, is to identify mechanisms of Black-White sleep disparities
and the mechanisms that account for Black-White differences in ADRD risk. The study includes annual
assessments across 3 years to assess sleep duration and quality, cognitive functioning, inflammatory
biomarkers (e.g., CRP, IL-6), life stressors (e.g., perceived neighborhood disorder), and resilience factors (e.g.,
spirituality, coping) in a sample of middle-aged (30-64 years) Black and White participants from the HANDLS
Study. The HANDLS Sleep Study includes three specific aims: Aim 1: determine if there are racial differences
in the daily coupling of sleep and mobile cognitive functioning and whether differences in this coupling are
moderated by life stressors (e.g., financial strain and neighborhood disorder); Aim 2: test longitudinal
associations among sleep and performance on mobile cognitive assessments and explore the role of life
stressors, protective factors (e.g., spirituality and neighborhood cohesion) and inflammation; Aim 3:
determine whether changes in the strength of the daily coupling of sleep and performance on mobile cognitive
assessments relate to racial differences in traditional annual measures of cognitive decline over 3 years, and
to elucidate the potential mediational role of inflammation. The HANDLS Sleep Study is innovative because it
will examine the association between sleep and cognitive functioning over various time intervals (daily and
annual), and it will also examine the relationship of life stressors, sleep, inflammatory biomarkers, and/or
resilient factors on racial disparities in cognitive decline. Furthermore, this research is significant because of its
potential to identify psychosocial and contextual factors related to impaired sleep and cognition that could
serve as the basis for evidence-based interventions.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will examine adverse and protective factors that modify Black-White disparities in sleep, will elucidate whether sleep disparities relates to Black-White differences in risk for cognitive impairment, and will identify best practices for research engagement with underrepresented populations. Thus, the proposed research is relevant to the NIH's mission to reduce and/or eliminate health differences that are commonly observed between Blacks and Whites as well as enhance research engagement with diverse communities.